Illuminating Heme Trafficking and Signaling Pathways in Health and Disease

PROJECT SUMMARY
The long-term objectives of this proposal are to elucidate the molecules and mechanisms that mediate heme
trafficking and signaling in health and disease. Heme is an essential but potentially cytotoxic metallocofactor,
signaling molecule, and nutritional source of iron. All heme-dependent processes require that heme is safely
transported and trafficked from sites of uptake or synthesis to heme dependent or regulated proteins located
throughout the cell. However, the molecules and mechanisms that mediate the mobilization of heme for
trafficking and signaling are poorly understood. Further, the spatio-temporal dynamics of heme trafficking are
unknown. This is in large part due to the lack of tools available to image labile heme pools relevant to it
biodistribution. The Reddi lab has recently overcome these technological barriers by generating genetically
encoded ratiometric fluorescent heme sensors and hemoproteomics approaches to characterize heme
trafficking and signaling dynamics. This proposal will focus on integrating molecular genetic, biochemical,
biophysical, cell biological, and chemical biology approaches towards elucidating: a. heme transport and
trafficking; b. heme-based signal transduction; and c. heme acquisition across a variety of model eukaryotic
cell lines, e.g. Saccharomyces cerevisiae and mammalian cell lines, and pathogens, e.g. Mycobacterium
tuberculosis and Candida albicans. To probe intracellular heme trafficking, genetically encoded heme sensors
will be used in gene deletion and over-expression screens to identify novel pathways for heme distribution and
trafficking. To probe heme signaling, hemoproteomics approaches and heme chelators will be deployed to
identify how heme signals are initiated, transmitted, and integrated to control metabolism and physiology. To
probe heme acquisition by human pathogens, heme sensors and hemoproteomics approaches will be
integrated to identify the mechanisms of heme uptake and utilization by Mycobacterium tuberculosis and
Candida albicans. Altogether, the proposed research will comprehensively address the mechanisms of heme
trafficking and signaling in various contexts relevant to health and disease.

Public health relevance
PROJECT NARRATIVE Heme is an essential cofactor, signaling molecule, and metallonutrient that is implicated in the pathogenesis of numerous human diseases. Using an innovative blend of genetic, biophysical, and biochemical approaches, we seek to characterize the molecules and mechanisms underlying heme acquisition, trafficking, and signaling in health and disease.